Substance Use SWG

PROJECT SUMMARY
Substance Use Scientific Working Group (SU SWG)
The drug crisis and ongoing HIV transmission in underserved parts of the U.S. has ignited a new focus on
advancing health equity, including HIV outcomes, in people who use substances. The UAB CFAR Substance
Use Scientific Working Group (SWG) was launched in 2022 with the overall objective of building a community-
engaged group of scientists and community members dedicated to ending HIV disparities in people with
substance use disorders. The SWG was developed to catalyze emerging investigators, research activities, and
partnerships aimed at substance-using populations affected by HIV. The rationale for the SWG is that HIV
continues to disproportionately impact people who use substances, specifically underserved populations in
Alabama and across the globe.1-4 Indeed, these marginalized groups have not experienced the individual and
population-level benefits of HIV prevention and treatment.5-7
At UAB, numerous investigators conduct substance use and HIV research, including those with established
independent research portfolios who are attracting new trainees to UAB. They desire opportunities to network
with one another around an HIV research agenda and collaborative opportunities to advance their work and
obtain more impactful funding. In first year of the SWG, SWG members met regularly to conduct a needs
assessment of substance use and HIV research from the perspective of trainees, fellows, and faculty. We
identified opportunities to leverage clinical populations and emerging investigators to successfully compete for
extramural funding and advance science. In the next cycle of CFAR funding, the SWG will achieve on the
following specific aims:
Aim 1. Develop diverse scientists with expertise in SUD and HIV research by facilitating structured
training opportunities.
Aim 2. Promote collaboration between experts in HIV, SUD, and health equity research by organizing
and hosting annual symposia highlighting innovative research and enabling collaborations.
Aim 3. Foster community partnerships to support SUD and HIV research by integrating an engaged
community with expertise in SUD and HIV into research activities.
The SWG will enable the UAB CFAR to make meaningful research contributions in HIV prevention and treatment
in people who use drugs through the development of new investigators, collaborations, and partnerships. The
expected outcome is a robust scientific community that works closely with community partners to compete for
extramural funding, engage substance-using populations for research, and accelerate progress towards ending
the HIV epidemic.